The Danger Model 2: how tissues control Immunity

Because our lab was shut down by the NIAID administration on April 1st, 2013, we focused on three projects that had some possibility of completion. We managed to finish one of these projects, but will continue the others through collaborations with other scientists on and off campus.

Ongoing projects from the Ghost Lab

1) (Collaboration with Bana Jabri, University of Chicago). IgA and B cell deficient mice show changes in intestinal epithelium indicating that these cells take up several aspects of immunity. Most of these changes only occur when the intestines harbor commensal organisms. we are now ascertaining which of the these commensals are responsible for stimulating the innate immune genes in the intestinal epithelium.